Core 4 - Rapid Multipathogen Detection For POCT and Natioal Disaster Readiness

CORE 4. TRAINING Introduction. We will train scientists, engineers, clinicians, and students on issues relating to POCT to facilitate development of technologies for critical-emergencv-disaster care. In conjunction with our multimedia education program presented in Core 3, we will offer a Fellow in-Training program locally (budgeted) and via the media presentations. We will use the latest multimedia technologies found in our new Medical Education Building learning suites for training and education purposes.